Structural biology collaborations

Key outcomes this year have centered around methods development and studies of intra- and extra-cellular signal regulation. As part of a collaboration with the CSB Biology Computing Section we published the latest developments in real time cryo-EM data processing using the SIMPLE software suite. We have identified a unique mechanism by which a Legionella pneumophila alters host mRNA decay by targeting the CCR4-NOT deadenylase complex. We have also contributed to a multi-disciplinary study that elucidated the structure-dynamical basis for signal transmission via a synthetic RNA device, with clinical implications for cancer immunotherapy. In addition we contributed structures to a study on the extracellular portion of the human Notch receptor, a critical developmental regulator dysregulation of which is linked to cancer development, and to an analysis of the Spd-2/CEP192 protein family of the centrosomal scaffold.